Understanding nicotine pouch adoption and longitudinal use patterns among U.S. adults

ABSTRACT
Nicotine pouches are oral, spit-free products that contain nicotine; while they resemble smokeless tobacco (SLT)
products, they contain nicotine powder rather than tobacco leaf. Sales of nicotine pouches have skyrocketed in
recent years and these products now account for more than 40% of the smokeless market share. Interest in and
use of nicotine pouches appears to be greatest among people who use other tobacco products, including
cigarettes, e-cigarettes, and SLT. As non-combustible products with no tobacco leaf, no vapor, and no inhalation,
nicotine pouches hold potential for harm reduction, and data indicate that nicotine pouches are more similar to
medicinal nicotine replacement therapy than to tobacco. Nicotine pouches could have a positive impact on
population health if adults use pouches to quit tobacco or switch to exclusive pouch use, provided that tobacco-
naïve young people do not initiate regular use; the harm reduction potential for these products is limited if dual
or poly product use is the dominant pattern. However, the trajectories of tobacco and nicotine product use among
adult tobacco users who have purchased and tried nicotine pouches remains unknown, making it difficult to
assess the potential public health impact of these products. Further, there are no studies that investigate detailed
nicotine pouch use behavior, contexts of use, and changes over time among adults who use tobacco at the
national level. This mixed methods R01 application will employ a nationally representative longitudinal survey
study, integrated with qualitative interviews, to advance the scientific understanding of nicotine pouch use at the
population level, generally among adults and specifically among those who use other products. Our study will
answer important questions about who is using nicotine pouches, reasons for use, methods, frequency, and
intensity of use, indicators of dependence, and product characteristics that influence use. Improved knowledge
about each of these factors is critical for understanding of the impact of these products on public health. We will
conduct a nationally representative 5-wave longitudinal web survey of 500 adults with a history of cigarette, e-
cigarette, or SLT use who currently (past month) or recently (past 6 months) used nicotine pouches to
characterize people who recently tried or use nicotine pouches and identify predictors of pouch adoption (regular
use) and progression to exclusive pouch use (Aim 1). With quarterly data collection, we will examine trajectories
of nicotine pouch use, including changes in frequency and intensity of pouch use, use of other products, and
nicotine dependence indicators over a 15-month period (Aim 2). We will also evaluate predictors of trajectories
and hypothesize that adults who transition to or maintain exclusive nicotine pouch use will exhibit lower nicotine
dependence than those who use multiple products. Finally, we will conduct semi-structured interviews with a
subset of survey participants at 3 time points to gain deeper understanding of how users differentiate various
oral tobacco and nicotine products, reasons for trying oral nicotine, reasons for continuing (or discontinuing)
pouch use, methods of pouch use, and perceptions about product brands and characteristics (Aim 3).

Public health relevance
PROJECT NARRATIVE The purpose of this mixed methods research is to generate U.S. data on adult uptake and longitudinal use patterns of nicotine pouches, a new oral nicotine product that does not contain tobacco and thus, may have potential as a reduced harm option for those who use other more dangerous tobacco products. These data are needed to evaluate whether adults may use nicotine pouches to successfully quit other tobacco product(s) or continue with poly-use, and to identify predictors of these trajectories. The findings of this project will advance our understanding of nicotine pouch use at the population level, generally among adults and specifically among those who use other products.